Pannexin 1 channels in diet-induced metabolic syndrome

PROJECT 3 PROJECT SUMMARY
Lack of physical activity along with a western diet and lifestyle is accompanied by an increased incidence of
obesity, diabetes, and fatty liver disease (NAFLD). NAFLD is considered an independent risk factor for
cardiovascular disease and encompasses multiple progressive disease conditions beginning with hepatic
steatosis, non-alcoholic steatohepatitis (NASH) and hepatic fibrosis, which is also associated with aging and
increased risk for cirrhosis and hepatocellular carcinoma. The progression of NAFLD with accompanying
hepatic fibrosis poses a significant health problem, culminating in liver transplant as the last resort. Treatment
options are limited and there is a tremendous need for novel therapeutic concepts. The mechanisms driving
NAFLD progression to fibrosis are largely unknown and may involve multiple insults by cell-derived danger-
associated molecular patterns (DAMPs) such as extracellular ATP and its metabolites, which were implied to
regulate hepatic inflammation and fibrosis. However, the mechanisms that control the release of ATP from
hepatocytes are not known. Our preliminary data demonstrate that hepatocytes express functional pannexin-1
(Panx1) channels that release ATP upon lipotoxicity-induced caspase-dependent cleavage. Pharmacological
inhibition or genetic deletion of Panx1 in hepatocytes protected mice against diet- and aging-induced steatosis,
steatohepatitis and hepatic fibrosis. Based on these data, we will examine the hypothesis that Panx1-
dependent ATP release from hepatocytes promotes fibrosis via activation of stellate cells and we will test if
inhibition of Panx1 channel function is a feasible therapeutic approach to combat NASH. In specific Aim 1 we
will investigate the effect of hepatic Panx1 deficiency (Panx1fl/fl/Albcre) and virus (AAV8)- mediated Panx1
ablation during the pathologically defined stages of fatty liver disease - steatosis, NASH, and advanced
fibrosis, using mice fed a high fructose, palmitate, cholesterol (FPC) diet for 5, 12 or 16 weeks. Virus-mediated
hepatic re-expression of Panx1 in Panx1-deficient mice and transgenic overexpression of Panx1 will be used
as gain-of-function approaches. We will develop novel liver-specific antisense oligonucleotide (ASO)-mediated
therapeutic approaches directed at Panx1, which will be tested in the FPC diet model, in transgenic APOE3-
Leiden/CETP mice, a “humanized” mouse model of metabolic syndrome, and in aging-induced fibrosis. In
specific Aim 2 we will test the hypotheses that (a) Panx1-dependent ATP release from hepatocytes regulates
fibrotic capacity of hepatic stellate cells via paracrine effects, and (b) ATP or its metabolites controls
metabolism of hepatocytes via Panx1-dependent autocrine mechanisms. Collectively, these data will provide
us new information on diet-induced metabolic complications that are now considered predisposing and
accelerating factors, part of the cardiometabolic syndrome; also, our new knowledge on liver fibrosis will also
have implications for cardiac fibrosis.